Cancer screening behaviors among people with and without HIV in All of Us

PROJECT SUMMARY
In the US, people with HIV (PWH) experience elevated mortality and morbidity due to cancer compared to the
general population. In fact, PWH diagnosed with non-AIDS defining cancers including lung, breast, and colorectal
cancers, are more likely to die due to their cancer diagnosis compared to those without HIV. Factors contributing
to the disproportionate burden of poor cancer outcomes among PWH are likely multi-factorial, including inter-
connected clinical and social factors, such as advanced stage at cancer diagnosis and barriers to cancer
screening for timely diagnosis. It is known that PWH are more likely to be diagnosed with advanced stage at
cancer diagnosis compared to those without HIV. Inequities in access to cancer screening among PWH are likely
a key contributor to lower cancer-specific survival rates among PWH. However, limited research exists
comparing trends in non-AIDS defining cancer screening recommendations. Breast, colorectal, and lung cancers
each have screening recommendations outlined and are preventable with routine, timely, guideline-adherent
screening. Detecting these cancers at later stage leads to more complex treatment trajectories and poorer
cancer-related outcomes. It is urgent to understand trends in cancer screening uptake and follow-up in the
general population of PWH to facilitate intervention development. However, existing research on cancer
screening trends on PWH focuses on populations engaged in routine HIV care visits, which may not reflect the
real-world barriers to screening PWH in the US face. We therefore propose to leverage data from the All of Us
Research Program to carry out the following aims: (Aim 1) Compare serial cross-sectional screening prevalence
for breast, colorectal, and lung cancers by HIV status, stratified by age, sex, and race/ethnicity; (Aim 2) Evaluate
time to follow-up after an abnormal cancer screening results by HIV status, stratified by age, sex, and
race/ethnicity; and (Aim 3) Estimate associations of multi-level social determinants of health (SDoH) with cancer
screening behaviors among PWH. The All of Us Research Program is an ideal data source to conduct this study
given the national recruitment efforts, the diverse study population, the recruitment of patients who are largely
served by federally qualified health centers (FQHCs), the unique linkage of electronic health record data as well
as in-depth survey data to obtain SDoH information at an individual level, and the availability of zip code to link
to contextual SDoH. The linkage of electronic health record data is particularly critical given we will have access
to HIV disease and care/treatment status, and detailed information regarding cancer screening behaviors as well
as treatment for any abnormal findings. The present proposal will lead to two important outcomes: (1) insights
on real-world trends into cancer screening and prevention behaviors among PWH to facilitate intervention
development tailored to PWH; and (2) an establishment of a research team and the infrastructure necessary to
translate findings into intervention development.

Public health relevance
PROJECT NARRATIVE Although cancer is a leading cause of mortality among people with HIV (PWH) in the US, data to inform tailored strategies to reduce preventable cancer-related deaths using recommended screening modalities are lacking. Through this proposal, we aim to address this gap in scientific knowledge, leveraging the All of Us data resource a national cohort including survey and a novel electronic health record-based linkage of multiple health systems throughout the US to gain real world insights into (1) patterns and trends in cancer screening uptake, follow-up, and outcomes among PWH compared to those without HIV and (2) social inequities (social determinants of health) in screening behaviors among PWH to identify actionable targets for intervention. Our results will elucidate mechanisms that could lead to the development of future interventions to: 1) improve coverage of cancer screening among PWH, 2) address barriers to cancer screening access and follow-up among PWH, and 3) optimize screening guidelines for PWH.